Control of Axon Degeneration by Palmitoylation

PROJECT SUMMARY
Degeneration of neuronal axons is a hallmark of diverse neuropathological conditions, ranging from acute nerve
injuries to chronic neuropathies and neurodegenerative diseases. If we better understood the mechanisms of
axon degeneration, we could devise new therapies to potentially slow or prevent axon degeneration and
ameliorate a range of neuropathologies. Recent findings suggest that one key event in axon degeneration is the
loss of ‘axon survival factors’, labile proteins whose continuous supply from neuronal cell bodies to distal axons
normally ensures axon integrity. The damage to axons that occurs after injury, or in chronic neuropathies,
disrupts the supply of survival factors and triggers distal axon degeneration. The best-known axon survival factor,
nicotinamide mononucleotide adenylyl transferase-2 (NMNAT2) requires the protein-lipid modification
palmitoylation for its fast axonal transport, but how palmitoylation contributes to NMNAT2 degradation is not fully
clear. I identified previously unrecognized phosphorylation sites on NMNAT2, whose phosphorylation by c-Jun
N-terminal kinase (JNK) triggers selective degradation of palmitoyl-NMNAT2 in cultured cells. While addressing
this question, I also realized that several other regulators of axon degeneration are palmitoylated, in addition to
NMNAT2. Given that palmitoylation is the only reversible protein-lipid modification, I asked if acute
depalmitoylation of NMNAT2 and/or other axonal proteins is important for axon degeneration. My results
revealed that pharmacological inhibition of protein depalmitoylases indeed protects axons from degeneration
and additional preliminary genetic data ascribe this protection to block of a recently described depalmitoylase,
ABHD16A. However, axon protection by depalmitoylase inhibitors is independent of NMNAT2 and other known
axon survival factors, suggesting that additional protein(s) are depalmitoylated after axonal damage to drive
subsequent degeneration. The hypothesis that underlies this proposal is that palmitoylation plays broad,
previously unrecognized roles in the control of axon degeneration. Experiments in Aim 1 will use a recently
generated phospho-mutant knockin mouse to define the importance of phosphorylation by JNK for NMNAT2
degradation and subsequent axon degeneration, both in cultured neurons and in vivo. Aim 2A will determine
whether ABHD16A is indeed the key depalmitoylase whose activity is required for axon degeneration and will
provide the first cell biological characterization of ABHD16A localization in axons. In Aim 2B I will break new
ground by comprehensively identifying axonal proteins that are rapidly depalmitoylated after axonal injury, in
order to identify those protein(s) whose acute depalmitoylation drives axon degeneration. Together, the results
of these studies will provide new insights into the cell biology of axonal (de)palmitoylation, will define key events
that drive axon degeneration, and could reveal new therapeutic strategies to ameliorate a host of
neuropathological conditions.

Public health relevance
PROJECT NARRATIVE Degeneration of neuronal axons occurs after acute nerve injury and in several neuropathological conditions, including chronic neuropathies. Several proteins that control axon degeneration are modified with a lipid called palmitate, a process called palmitoylation. The proposed research will define the importance of palmitoylation for axon degeneration and could reveal new therapeutic strategies to prevent axon degeneration in a wide range of neuropathologies and thereby benefit human health.